Administrative Core

Project Abstract (Admin Core)
The goal of the proposed Center to Accelerate Population Research in Alzheimer’s (CAPRA) is to serve as a
national resource to promote and accelerate observational studies that aim to inform government and
healthcare system actions to reduce the social, economic, and health burden of AD/ADRD. To achieve this
objective, CAPRA requires an administrative infrastructure that supports timely, well-designed studies using
complex population and healthcare data and incorporates input from experts locally, nationally, and
internationally. The Administrative Core for CAPRA will provide this infrastructure, management, and
communication and dissemination strategy necessary to implement the strategic vision of the CAPRA which is
to leverage the deep expertise at the University of Michigan (UM) and other institutions to enable new and
established investigators locally and nationally to initiate novel areas of AD/ADRD population research. To do
so, CAPRA will fund and support pilot studies, provide training materials, tools, and in some cases access to
secondary data relevant to AD/ADRD, and will also develop networks of experts with whom to consult and
collaborate. CAPRA’s structure and governance will include four Cores (Administrative, Pilot, External Network
and Research Resources Cores), a Steering Committee and an External Advisory Panel, all composed of
investigators across disciplines and areas of expertise that will generate the diversity of ideas necessary to
address the complex challenges posed by AD/ADRD. The foundation of CAPRA’s strength is the depth of
expertise that is represented by the leadership team and planned affiliates, the institutional supports provided
by UM, and the collaboration with the other aging centers at and outside UM. Drs. Bynum and Langa as the
Administrative core leaders have broad connections across relevant academic, healthcare, policy-making and
stakeholder groups. The CAPRA Administrative Core will serve several functions including: management of
advisory committees; administratively supporting the pilot study decision process; grants management and
tracking; providing an infrastructure for delivery of technology-enabled training support and publicly accessible
data and algorithms; coordination of in-person opportunities for scientific networking activities, and carrying out
the communications and engagement strategy across our affiliates, internal and external partners, and
stakeholders such as policy makers. The proposed CAPRA has great opportunity and potential to accelerate
the advance of the science of population and healthcare research in AD/ADRD. CAPRA’s success depends on
the infrastructure, organization and management provided by the Administrative Core.